OMEGA COPD Trial

OMEGA COPD Trial SUMMARY
Chronic obstructive pulmonary disease (COPD) is a leading cause of death in the United States, with significantly
higher prevalence, morbidity, and mortality in lower income communities. Poor dietary intake, and in particular
low omega-3 polyunsaturated fatty acid intake, is a common problem in low-income communities and has been
associated with adverse outcomes in populations with respiratory disease. We, and others, have shown that a
diet defined by lower omega-3 intake is associated with worse COPD respiratory outcomes. Because omega-3
polyunsaturated fatty acids obtained through diet are responsible for arbitration of pulmonary and systemic
inflammation through the eicosanoid pathway, omega-3 intake may also be a critical protector against the
adverse effects of pro-inflammatory exposures related to COPD respiratory morbidity. Our group has further
demonstrated that indoor air particulate matter (PM) levels are linked to worse respiratory morbidity in individuals
with COPD, and indeed a diet low in omega-3 likely augments the adverse effects of pollutant exposure on
respiratory morbidity. Unfortunately, low-income individuals with COPD often have diets with omega-3 intake
levels well below recommended levels in addition to relatively high levels of indoor PM exposures, leading to
heightened risk of poor respiratory outcomes. A dietary intervention, designed to increase intake of omega-3 in
food sources, has the potential for high-impact within this vulnerable group. In this proposal, we will test a dietary
intervention based in omega-3 rich foods, with the aim of improving respiratory health (Aim 1), and protecting
against the adverse effects of environmental exposures (Aim 2) in low income adults with COPD. The
intervention will overcome several common nutritional barriers in low-income communities: food insecurity (a
voucher will be provided), food access and fresh food availability (home delivery and choice from a range of
healthy food options), and support in achieving and sustaining dietary change (regular contact with a dietary
health coach trained to support personal behaviors surrounding healthy food choices and provide culturally-
informed education around nutrition and food preparation). Through qualitative methods (Aim 3), we will also
explore barriers and facilitators of the intervention in order to optimize sustainability of future implementation
strategies. Results will comprehensively address the impact of an evidence-based nutrition intervention on
COPD health, and provide a framework for dietary intervention within other chronic diseases disproportionately
impacting susceptible, low-income populations. Positive results will be buoyed by existing infrastructure within a
leading national grocery delivery service supportive of expanding access to healthy foods, providing a ready
platform for sustainability and dissemination beyond the study and with immediate policy implications.

Public health relevance
PROJECT NARRATIVE COPD is a leading cause of death in the US with low-income individuals experiencing increased prevalence and morbidity; and the proposed research represents new lines of investigation that build on previous studies identifying that dietary intake of omega-3 polyunsaturated fatty acids was well below recommended levels for the majority of participants in a low-income COPD cohort, and that lower intake levels were associated with worse COPD outcomes and increased susceptibility to indoor air pollution exposures. The OMEGA COPD Trial focuses on a food delivery dietary intervention targeting increased omega-3 intake to determine whether dietary modifications can improve COPD outcomes and attenuate the adverse effects of particulate matter exposure on respiratory health. Results will comprehensively address the impact of an evidence-based nutrition intervention on COPD health and provide a framework for dietary intervention within other chronic diseases disproportionately impacting susceptible, low-income populations.